NEUROENDOCRINE CONTROL OF THYROID STIMULATING HORMONE SECRETION

TSH is secreted in discrete pulses. The origin of TSH pulsations is unknown. This protocol will determine whether TRH infusion alters pulse amplitude or frequency.